Clinical Core

ABSTRACT CLINICAL CORE
The Clinical Core (CC) supports the Einstein Aging Study Program Project (EAS P01) by collecting data for
key measures used to characterize the cohort, to define the primary cognitive outcomes for this P01 which
include cognitive performance, cognitive decline, mild cognitive decline and dementia. The core also manages
the collection of robust data regarding exposures and risk factors to be used by the Projects. These measures
cover multiple domains and include objective and subjective assessments collected using both conventional
clinic-based and ambulatory methods using smartphones and wearable devices. This Core has a strong track
record utilizing multiple modes of data collection including telephone evaluations, in-person and virtual visits,
ambulatory assessments, and at-home surveys to complete annual evaluations. The Clinical Core will 1) obtain
informed consent; 2) conduct evaluations that include medical and epidemiologic histories, psychosocial and
behavioral reports, annual neurological and neuropsychological evaluations, physical measures
(anthropometrics, blood pressure); 3) obtain fasting blood samples; 4) train participants in ambulatory and
remote data collection techniques; 5) conduct consensus case conferences to determine clinical cognitive
diagnosis (mild cognitive impairment, dementia and dementia subtypes); and 6) manage participant flow to the
Projects and Cores including MRI and consent for brain autopsy. The CC trains and manages the study staff
who conduct these assessments; we have an excellent record of staff retention across many years, who live in
the surrounding community and understand the needs and concerns of participants. The Clinical Core
cooperates with the Administrative Core to collect follow-up medical and neuropsychological information for
study participants no longer able to return for in-person evaluations. Data from the Clinical Core are used to
determine participant eligibility for the MRI sub-study. Finally, with the Biomarker Core, the Clinical Core
distributes samples to the appropriate labs, and banks biological specimens for current and future assays.

Public health relevance
NARRATIVE CLINICAL CORE The CC performs the essential role of rigorous clinical characterization of study participants to create a common foundation for use by the other Cores and Projects, including baseline assessment of cognitive status and progression over time. It is innovative in its use of both conventional and ambulatory methods to elucidate risk factors and cognitive outcomes in individuals’ natural environments. The CC has a strong track-record utilizing multiple modes of data collection, including telephone evaluations, in-person and virtual visits, ambulatory assessments, and at-home surveys to characterize participants.